Regulation of dynamic actin networks during epithelial morphogenesis

Project Summary/Abstract
Embryonic development requires the dynamic remodeling of epithelial sheets as the embryo
transforms itself during morphogenesis. Embryonic epithelia are hybrid tissues: they must
maintain their integrity as mechanically integrated cell sheets, connected by cell-cell junctions,
yet their cells must also retain the ability to dynamically change shape and position. The actin
cytoskeleton is central to these activities; cells must link actomyosin networks dynamically to the
cell surface via junctional complexes, and they must dynamically polymerize actin networks
during cell shape changes and cell migratory events. Our goal is to understand the dynamics of
actin networks during rapid cell shape change and during directed cell rearrangement in
embryos. Our goal is a multidisciplinary, integrated analysis of morphogenetic movements in
embryos that unites detailed structural analysis, single-molecule biophysics, genetics, and
dynamic in vivo analysis, in an "Angstroms to embryos" approach to morphogenesis. Upgrading
our ability to image living embryos using high-numerical aperture DIC optics and modern USB3-
based cameras controlled by the NIH-supported, open-source software MicroManager will allow
us to extend our analyses by providing higher throughout, better resolution, and enhanced focal
stability relevant to all aims of the parent award.

Public health relevance
Project Narrative Understanding how cells attach to one another and move between one another is important for understanding many common birth defects, and many of the same processes that are tightly regulated in embryos are misregulated in cancer cells as they lose their connections to one another and invade the body. This supplement proposes to acquire a replacement, upgraded digital four-dimensional (three dimensions of space over time) microscopy system to acquire high-speed, high-resolution datasets without vertical drift. This system will support all aspects of the parent award, which examines how actin – a protein essential for cell movements – works alongside proteins that regulate cell adhesiveness to build strong connections between cells and to help them avoid injury, and how signals regulate the actin machinery that allows cells to change position in the embryo.